Dependence of memory on precisely coordinated oscillations

PROJECT SUMMARY
Brain oscillations are thought to be critical for cognitive functions and are disrupted in all major
neurological and psychiatric disorders, such as Alzheimer’s disease, epilepsy, depression, and
schizophrenia. There has been increasing interest in understanding the relation between neural
computations and oscillatory patterns in the healthy and diseased brain because oscillation patterns
can be targeted for treatment with noninvasive and invasive stimulation devices. While most brain
rhythms are generated by either neuronal pacemakers or local circuits, breathing generates rhythmic
brain activity by an external loop. Nasal air flow stimulates olfactory sensory neurons which generate
respiration-related oscillations (RROs) in the olfactory bulb (OB). RROs have been shown to widely
propagate to cortical areas, including piriform cortex (PC), prefrontal cortical areas, lateral entorhinal
cortex (lEC), and hippocampus (HC). In HC, RROs can be detected in parallel with pacemaker-
generated theta oscillations, which are critical for memory function and overlap in frequency. It is not
clear to what extent the two types of oscillations are merely parallel phenomena or functionally
coordinated to support neural computations. We hypothesize that RROs and theta oscillations do not
globally couple, but that subpopulations of neurons across brain regions are synchronized with each
oscillation pattern across different memory phases. To address this question, we will perform
recordings and manipulations of local field potentials (LFPs) and neuronal firing patterns in odor-
guided working memory tasks, where both types of oscillations are prominent. In Aim 1, we will
determine whether RROs, theta oscillations, and oscillations at higher frequencies are coordinated
across brain regions in an olfactory working memory task by recording LFPs and/or single-units in
the OB, anterior PC, lEC, ventral HC, dorsal HC, and medial prefrontal cortex (mPFC). These brain
regions are included because RROs and canonical theta oscillations have been reported in all of these
regions and because these brain regions are thought to be critical for working memory performance.
In Aim 2, we will then use optogenetics to change the frequency of RROs and canonical theta
oscillations to determine during which phases of working memory they are critical for task
performance. Finally, in Aim 3, we will use a match/non-match version of the odor-guided working
memory task to determine how the initial sensory code is transformed into activity patterns that
remain informative over the retention interval. Taken together, our aims will reveal how neuronal
activity patterns are coordinated by two types of oscillations during working memory. A mechanistic
understanding of brain oscillations that support memory computations is foundational for devising
and applying brain stimulation therapies to improve memory in neurological and psychiatric diseases.

Public health relevance
PROJECT NARRATIVE Healthy cognitive processing is associated with well-defined oscillatory neuronal activity, and some aspects of brain oscillations have been reported to be disrupted in any of the major psychiatric and neurological diseases. Selectively targeting brain oscillations for treatment could thus profoundly improve cognitive function in disease. To provide a foundation for such therapies, our objective is to show to what extent brain stimulation affects local neural computations as well as long-distance communication between brain regions, and our studies will therefore provide a neurobiological foundation for further developing invasive and non-invasive brain stimulation therapies.